Targeting Transcription and Splicing in Cancer

OVERALL
PROJECT SUMMARY
The overall goal of this Program is to understand how transcription and splicing regulation is altered and co-
opted by cancer cells to promote tumor initiation and progression, and to apply this knowledge towards
development of new therapeutic approaches. During the past 50 years, the strong underlying basic science
foundation of the Program Project has allowed members to identify vulnerabilities in cancer and develop novel
and highly specific therapeutic strategies. This Program continues to take a multi-pronged approach grounded
in basic cancer research to identify and disrupt the molecular dependencies underlying cancer.
Within this Program, there are three highly integrated Projects (Targeting oncogenic transcription factors; RNA
Splicing dysregulation in cancer; Regulatory RNAs as cancer drivers and dependencies) and four innovative
Cores that are using cutting edge technologies to study the molecular mechanisms of cancer biology. To achieve
the Program's goals, these studies will exploit novel organoid models of human cancers, pioneering imaging
modalities in animal models, therapeutic antisense oligonucleotide strategies against otherwise undruggable
targets, and cutting-edge methods in biochemistry, cell biology and molecular biology. The researchers will
interrogate the basis of two of the most devastating types of tumors, basal-like carcinomas of the breast and
pancreas. All of this work is supported by four Cores that provide access to technologies, services, and expertise
that all combine to enhance productivity and promote interactions.
The interactive and collaborative nature of this Program guides each of these Projects beyond their singular
potential. Research in all three Projects touches on overlapping themes and benefits from the expertise of the
other Program members. Together, this Program is making significant progress towards its goal of identifying
novel therapeutic targets that will substantially impact cancer treatment.

Public health relevance
OVERALL PROJECT NARRATIVE Dysregulation of transcription and splicing is pervasive across all human cancers, however very few approved therapies exist that target these processes. This Program Project seeks address this deficiency through target discovery, validation, and deep mechanistic investigation. The insights gained through this research are likely to reveal highly specific, new vulnerabilities in cancer cells that will be the basis of innovative drug development in the fight against cancer.